Stanford TRANSFORM I2T Program

Project Summary/Abstract
The majority of human health advances are made at intersection of clinical medicine and scientific innovation.
At this essential intersection, we need a cadre of trained physician-investigators who can ask the right
questions, do the right experiments, and move medicine into the future. Despite the urgent need for this cohort,
the number of physicians engaged in research is diminishing. The objectives of “TRANSFORM I2T” (Training in
Research for New Stanford Faculty Or Residents Motivating Infection, Immunology, and Transplantation) are
to provide resident, clinical fellow, and junior clinical faculty physicians with research experiences in the
formative years of their careers, in order to engage clinician-scientists to participate in basic, translational, or
clinical research in NIAID mission areas. By exposing residents during their early clinical training, we hope to
engage them as physician-investigators in Infectious Diseases, Immunology, and Transplantation, so that they
may have a significant impact on the health-related research needs of the nation. By exposing clinical fellows
and junior clinical faculty to team-science research opportunities, we hope to spark specific interests that will
inform and direct careers in these subspecialties, and to train physicians for successful careers as
collaborative investigators. We propose to prepare all trainees—irrespective of whether they intend to conduct
their research at the bench or from the bedside—to translate their scientific discoveries into clinical practice. To
this end, we request support for 5 participants each year, for a research training period of 3 to 11 months.
Resident physician candidates will be selected from the exceptional internal medicine training program at
Stanford – a program that has consistently attracted some of the most highly qualified graduates from
research-intensive Schools of Medicine. We anticipate that the Divisions of Infectious Diseases/Geographic
Medicine and Immunology/ Rheumatology will provide the majority of fellow and junior faculty candidates.
Fellows and junior faculty from other divisions in which solid organ transplantation plays a major role (e.g.,
Nephrology, Gastroenterology and Hepatology, and Pulmonary and Critical Care Medicine) will also be invited
to participate. Selection into TRANSFORM I2T will be based on exceptional academic record, faculty
interviews, and a strong interest in research. Every effort will be made to attract participants from
underrepresented minority and other disadvantaged groups (e.g. disabled persons, long “distance traveled”).
The program intends to meet a recognized need for clinicians trained in research methods relevant to
Infectious Diseases, Immunology, and Transplantation - all recognized strengths of the Department of
Medicine at Stanford University School of Medicine. Graduating resident physician participants from this
program are expected to transition to research-intensive fellowships; fellow and junior faculty participants will
be well prepared to enhance and “transform” public health through the intersection of clinical medicine and
research.

Public health relevance
Project Narrative The objectives of the Stanford TRANSFORM I2T grant are to engage M.D. resident and fellow trainees and junior faculty in NIAID-relevant research. We aim to expose residents, fellows and junior faculty to a meaningful team-science research experience, thus engaging them as future physician-investigators so that they may have a significant impact on the health-related research needs of the nation. The training program will exploit the world-class resources and leadership at Stanford University in basic science, translational, clinical, and outcomes/epidemiology research in Infectious Diseases, Immunology/Rheumatology, and Transplantation ensuring that trainees will be well prepared to enhance public health through the intersection of clinical medicine and research.